Mechanisms of regulatory T cell processes by IL-2" - TRANSFER to UNM

Autoimmune disease is one of the leading causes of death for young and middle-aged women in the US.
These diseases are mediated by autoreactive T cells, which are naturally contained by T regulatory cells
(Tregs). Non-functional mutations in the IL-2 receptor (IL-2R) lead to autoimmunity due to deficiencies in Treg
survival and function. This finding is corroborated by in vivo mouse models, leading to the widespread
conclusion that IL-2 is important for Treg survival. However, recent data indicates this is oversimplified. Our lab
studies a mouse model in which the alpha chain (CD25) of the IL-2R on peripheral Tregs is conditionally
ablated. CD25 knockout Tregs demonstrate a disproportionate loss of central Tregs, which are long-lived
circulating Tregs that give rise to effectors to maintain self-tolerance. Bulk knockout Tregs also display
disruptions in critical Treg processes such as proliferation, survival, metabolism and suppressive function.
Additionally, there is an absence of highly suppressive terminally differentiated Tregs in IL-2R mutant animals,
indicating IL-2 may regulate the development of highly suppressive Tregs required for maintain peripheral
tolerance. Given these findings, IL-2 signaling controls processes that are essential for the prevention of
autoimmunity and understanding this role can provide therapeutic avenues to manipulate this population. Aim
1 will determine the effects of IL-2 on survival, proliferation, function and metabolism in Treg subsets.
Using flow cytometry and in vitro assays, proliferation, apoptosis, survival, function and metabolism will be
examined in Tregs subsets with and without IL-2 signaling. This aim will inform the extent to which IL-2
regulates cellular processes in Tregs subsets to further define the way by which IL-2 maintains Treg
populations. Aim 2 will evaluate the role of IL-2 in Treg differentiation and heterogeneity. Due to defects
observed in the differentiation of Tregs in the setting of IL-2, this aim will use adoptively transferred Treg
subsets with and without IL-2 signaling to determine how IL-2 regulates development of eTregs from cTregs.
Aim 3 will define the distinct IL-2 dependent transcriptional and epigenetic processes in cTregs versus
eTregs. This aim will harness high throughput techniques such as RNAseq and ATAC-seq to correlate
epigenetic and transcriptional changes as a consequence of IL-2 signaling, or lack thereof, in Treg subsets. By
defining IL-2-dependent pathways and cellular processes that differ between them, these findings will be
integrated with those in aim 1 to provide a clear role for IL-2 in regulating the cellular processes in each Treg
subset. The main objective of this fellowship research is to define IL-2 driven processes coordinating Treg
survival and homeostasis that are acutely relevant for understanding therapeutic applications of this cytokine
and broadly relevant for understanding autoimmune disease.

Public health relevance
Project Narrative Regulatory T cells (Tregs) are one of the main immune components that control autoimmune disease and are selectively disrupted in the setting of Interleukin-2 (IL-2) signaling deficiencies. Numerous studies are examining the therapeutic potential of low-dose IL-2, but these evaluations would benefit by a more complete knowledge concerning the mechanisms by which IL-2 effects mature Tregs. This study will address fundamental questions surrounding the contribution of IL-2 receptor signaling for Treg survival, differentiation, and function to aid in the therapeutic application of this cytokine and to better define potential targets related to IL-2/IL-2 receptor genetic risk for autoimmunity.